Building Tools and Community to Make Pangenomes Accessible

PROJECT ABSTRACT
The human pangenome encompasses global genetic diversity missing from any single reference genome. This
project will develop sequence alignment, population genetic, and visualization tools that enable new ways to
access and understand the pangenome. These innovations aim to catalyze discoveries by making expansive
pangenome resources more intuitive for diverse genomics communities. We will create sequence mapping and
alignment methods that allow rapid search and comparison to complement graph-based pangenome approaches.
Using succinct data structures, our techniques will enable interpretation of pangenomes while also developing
sublinear indexes of the pangenome for sequence search based on exploring all-vs-all genome homology. For
population genetics, we will implement analyses for GWAS, heritability, selection, and phylogeny directly on a
novel encoding of pangenome graphs based on node coverage, which captures allele zygosity across the entire
pangenome. This representation naturally captures all variation including everything from SNPs to structural vari-
ants to centromeric haplotypes. To aid exploration, we will build interactive visualizations using GPU-accelerated
algorithms to enable real-time interaction with massive graphs which provide a human-scale interface to the
overwhelming diversity of data present in pangenomes. Throughout this work, we will engage diverse genomics
communities via open source software, hands-on workshops, conferences, and integration with public databases.
We will target bioinformaticians, geneticists, clinicians, and evolutionary biologists to reﬁne methodology. Broader
pangenome adoption can help overcome reference bias, empower more equitable genomics, and increase un-
derstanding of human genetic diversity to advance health. Our user-focused pangenome tools seek to make
these expansive resources tangible and integrated for the genomics community to catalyze new ﬁndings.

Public health relevance
PROJECT NARRATIVE The human pangenome encompasses global genetic diversity missing from the reference genome. This project will develop sequence alignment, population genetics, and data visualization tools that enable new ways to access and understand the pangenome. These innovations aim to catalyze discoveries by making expansive pangenome resources more intuitive for diverse genomics communities.